Mechanisms of proinflammatory glial activation in retinal degeneration

Project Summary / Abstract:
The goal of this project is to define dysregulation in key immune checkpoints that regulate microglial activation,
including TREM2-TYROBP-APOE signaling, which is associated with a common pro-inflammatory state, and
how this contributes to progression of degeneration in age-related macular degeneration (AMD). To explore
the hypothesis that proinflammatory microglia are a key component of the pathobiology of retinal degeneration
in AMD, we will use CRISPR-Cas9 knockout of key immune checkpoints in human iPSC-derived microglia and
expose them to multiple components of extracellular deposits that are characteristic of this disease (Aim 1).
This will validate these pathways as potential targets for novel therapeutics aimed at limiting inflammation in
AMD. In Aim 2, we will perform single-nucleus transcriptional profiling of retinal microglia from individuals with
early and late stages of AMD, and those of controls. In Aim 3, we will investigate how transcriptional alterations
in microglia are influenced by the pathologic tissue microenvironment by performing highly multiplexed spatial
analysis of RNA and protein in retinal tissue affected by AMD-associated lesions using spatial co-indexing of
transcriptomes and epitopes for multi-omics mapping by highly parallel sequencing (spatial-CITE-seq).
Assaying transcriptional states in disease associated microglia in retina and within AMD lesions directly using
human samples will provide a new paradigm to understand AMD and probe the largely unaddressed question
of the role of microglia in AMD pathogenesis. It will also set the stage for further study of neuroinflammatory
biology using AMD as a paradigm to discover principles with application to other neurodegenerative diseases.
This mentored clinical scientist research career development award is designed to help Dr. Marcello DiStasio
achieve his long-term career goal of an academic career with a focus on neuroinflammation in degenerative
diseases of the retina. His Mentor, Dr. David A. Hafler, is a leader in the field of neuroimmunology and is
committed to the scientific development and execution of the project. He is the William S. and Lois Stiles
Edgerly Professor and Chairman, Department of Neurology and Professor of Immunobiology, Yale School of
Medicine, and is the Neurologist-in-Chief of the Yale New Haven Hospital. Co-Mentor Dr. Brian P. Hafler is an
Assistant Professor of Ophthalmology and Visual Science and of Pathology whose lab focuses on retinal
disease using advanced genomics technologies. The environment at the Yale School of Medicine has a strong
and established research program related to immunology and neuroscience, and includes the Center for
Neuroinflammation, where the research will be conducted. The experience, knowledge, and skills gained
through the research plan and career development activities will form the basis for future studies as Dr.
DiStasio transitions to independence as a clinician-scientist.

Public health relevance
Activation of the innate immune system has been recognized as a significant component of numerous forms of neurodegenerative disease. This project aims to characterize the factors influencing microglia, key mediators of inflammation in the retina, to switch from homeostatic to proinflammatory functions as part of disease progression in age-related macular degeneration. Using novel methods for gene knockout of key pathways in human stem-cell derived microglia-like cells, single-cell RNA sequencing analysis, and highly multiplexed molecular mapping in tissue with digital histologic analysis, this work will identify tissue microenvironment factors and immune checkpoints representing novel therapeutic targets for retinal degeneration.